MICRO CONTRACT FOR DRUG METABOLISM AND PHARMACOKINETICS (DMPK) SERVICES FOR BLUEPRINT NEUROTHERAPEUTICS NETWORK (BPN), HEAL AND BIOLOGICS. CATALOG #: NA POP: JULY 8, 2025 TO JULY 7, 2026.

NINDS is seeking an executive (senior scientific)-level, industry-experienced drug discovery and development subject matter expert with a background in Drug Metabolism and Pharmacokinetics (DMPK) to provide technical support to the following Extramural Programs:
• The Blueprint Neurotherapeutics Network for Small Molecule (BPN-Small Molecule);
• NIH Blueprint Neurotherapeutics program (BPN);
• Other NIH neuroscience-focused drug discovery and development programs.

The NIH Blueprint for Neuroscience Research, a collaborative framework that includes the NIH Office of the Director and 12 NIH Institutes and Centers that support research on the nervous system, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and Contract Research Organization (CRO) support through Phase I clinical testing. Each project is directed by a Lead Development Team (LDT) composed of the Principal Investigator (PI), industry subject matter experts hired by NIH, and NIH staff. This team maps out a research strategy, including milestones, and oversees implementation by CROs. Bioactivity and efficacy studies that are funded through an award to the PI; other research services can be provided through NIH contracts

Public health relevance
This contract for DMPK Subject Matter Experts [SME] is directly related to human healthcare and safety as DMPK SMEs support NINDS funded projects to develop drugs for neurological conditions and non-opioid drugs for pain. Furthermore, this contract action is to implement the NINDS’ Directive to reduce the burden of neurological diseases and pain for all people.